DP21-001 Alabama Pregnancy Risk Assessment Monitoring System (PRAMS)

Project Summary/Abstract
The main objective of the Alabama Pregnancy Risk Assessment Monitoring System (PRAMS)
Project is to provide accurate data to researchers, health care providers, and policymakers in order
to ultimately improve the health of Alabama mothers and infants. This objective is in accordance
with the Alabama Department of Public Health’s mission to improve the health of all Alabamians.
The design and methods of the PRAMS project include drawing a sample from the state birth
certificate registry file and sending surveys, according to protocol, to the mothers who are selected.
The survey contains information concerning the behaviors and experiences before, during, and
shortly after the pregnancy, which is vital to determining Alabama Public Health policy and
produces timely, high quality data representative of the jurisdiction’s population to monitor risk
factors for maternal and infant health. PRAMS provides state-based data for key maternal and
child health indicators that can be tracked over time. The PRAMS team conducts comprehensive
analysis of PRAMS data based on a jurisdiction specific analysis plan designed to inform
programmatic activities, research, and public health practice. Through various reports, the team
translates and disseminates analytic results into useable information for public health action that
can guide program development and evaluation, in collaboration with the Alabama PRAMS
Steering Committee. PRAMS reports provide state-specific data on maternal behaviors and
experiences, to be used for planning and assessing perinatal health programs, and for describing
maternal experiences that may contribute to maternal and infant health. The overall goal of
PRAMS is to reduce infant morbidity and mortality, and maternal morbidity by influencing
maternal behaviors during and immediately after pregnancy.

Public health relevance
Project Narrative The Alabama Pregnancy Risk Assessment Monitoring System (PRAMS) Project is a survey sent to women who have recently given birth. The survey covers various topics concerning their health behaviors and experiences before, during, and after the pregnancies. The PRAMS survey is a comprehensive tool that provides an accurate picture of the health of mothers and infants in Alabama. PRAMS data will be used to create informational materials (e.g., fact sheets, data brief, infographics) to educate the public and providers on health and safety topics, such as the importance of receiving dental care during pregnancy, safe sleep for infants, and nutrition during pregnancy. PRAMS data will be presented to highlight the importance on overall health care during pregnancy and barriers to care faced by pregnant women in Alabama. PRAMS data will be used by the state of Alabama to plan and review programs and policies aimed at reducing health problems among mothers and babies. The data will also be shared with other state and local agencies that have important contributions to make in planning maternal and infant health programs and to develop partnerships with those agencies.